Fractional flow reserve versus Angiography for Multivessel Evaluation (FAME) 3 Extended

PROJECT SUMMARY/ABSTRACT
Coronary artery disease (CAD) remains the major cause of morbidity and mortality in adults in the United
States. In patients with 3-vessel CAD not involving the left main coronary artery, percutaneous coronary
intervention (PCI) or coronary artery bypass graft surgery (CABG) can improve outcomes. Older studies have
shown that the more invasive option, CABG, significantly reduces mortality during long-term follow-up
compared with PCI. However, these studies did not use contemporary methods to perform PCI, such as
measuring an index called fractional flow reserve (FFR) with a coronary pressure wire or using current-
generation drug-eluting stents (DES), both of which significantly improve outcomes after PCI.
The Fractional flow reserve versus Angiography for Multivessel Evaluation (FAME) 3 trial randomized 1,500
patients to FFR-guided PCI with current generation DES or to CABG and found that at 3 years there was no
significant difference in the composite of death, myocardial infarction (MI) or stroke between the two strategies.
There was a reduction in MI in the CABG group. Longer-term follow-up is critical to determine if contemporary
PCI results in similar survival as CABG.
The primary aim of this project is to determine if 10-year mortality is different after FFR-guided PCI compared
with CABG. We will perform 10-year follow-up in the 1,500 patients randomized in the FAME 3 trial to
determine if FFR-guided PCI is non-inferior to CABG with respect to mortality. Secondary aims include
assessing quality of life and angina relief at 10 years in the two groups. This novel approach aims to report
holistic outcomes not limited to the cardiovascular system, with emphasis on the patient’s life journey.
Additionally, we will compare individual rates of secondary clinical outcomes including MI, stroke, and repeat
revascularization at 10-year follow-up after PCI or CABG. This study will uniquely position us to answer the
question regarding the relationship between MI and long-term mortality, and repeat revascularization and
quality of life. This project will contribute significantly to the evidence base for an important public health
matter, namely determine whether PCI results in similar survival as CABG at 10 years in patients with 3-vessel
CAD.

Public health relevance
PROJECT NARRATIVE Coronary artery disease, or narrowing of the blood vessels that provide blood to the heart, is the most common cause of death in the United States and can be treated with either coronary bypass surgery or coronary stent placement. This study will evaluate outcomes, including death and quality of life, at 10 years in 1,500 patients with coronary disease who have already been randomized to either bypass surgery or stenting. If outcomes with stenting are equivalent to bypass surgery, it will provide millions of patients with a less invasive option for treatment of their coronary disease.